Assessing Neuronal Vulnerability in the Entorhinal Cortex due to Alzheimer's Disease Pathology

PROJECT SUMMARY
Understanding how specific neurons in a selectively vulnerable region such as the EC are affected is critical to
unraveling the mechanisms underlying Alzheimer's disease onset. We and others have shown that neuronal
hyperexcitability is the key driver that makes pathologies and symptoms worse and ameliorating hyperexcitability
slows down AD-related symptoms. However, it is unclear if the hyperexcitability is due to an increased firing of
excitatory neurons or decreased firing of inhibitory neurons. We aim to understand the mechanisms underlying
hyperexcitability by studying the excitatory and inhibitory neurons in the EC of App and tau knockin mice.
To determine which type of neurons are affected early in the EC, we will investigate: Aim 1- Excitatory neurons
in the App knockin (AppNL-G-F) and tau knockin (hTau-KI) mice by using intersectional approach with
optogenetics and chemogenetics in combination with electrophysiology recordings and behavior and Aim 2-
Inhibitory neurons (parvalbumin- PV and somatostatin- SST) in the AppNL-G-F and hTau-KI mice as in aim 1.
Using Cre-specific mice to target excitatory and inhibitory neurons in combination with opto- or chemo- genetic
approach we will not only identify selectively vulnerable neuron-type, but we will also modulate their activities to
restore their function and test if behavioral deficits are reversed. We will use novel computational approaches
such as decoding and remapping to detect subtle changes in firing activity of EC neurons. We will also assess
how amyloid beta or tau affect different neuron types in the EC, and if downstream hippocampal neurons are
affected too. The results of the proposal will definitively answer if hyperexcitability of neurons due to AD
pathologies is caused by dysfunction of excitatory or inhibitory neurons. The sensitive computational methods
used in this proposal allow for measurement of subtle electrophysiological changes not possible previously and
therefore might allow for development of better diagnostic tests that could be translated and modified for clinical
use in humans.
Overall, the proposal aims to identify which neurons in the MEC are most vulnerable to AD pathology. The
proposal is highly innovative as it will use a combination of sophisticated in vivo recording in two AD mouse
models in combination with optogenetic and chemogenetic tools to identify specific cell type and modulate
neuronal firing to restore function. The results from the study will be highly significant as therapeutic or clinical
approaches to target vulnerable cell type could be identified. The proposal brings together diverse fields
(electrophysiology, pathology and computational neuroscience) applying large-scale recording techniques to
record ensemble populations of neurons to interrogate what causes hyperexcitability in a vulnerable brain region
that is dysfunctional in Alzheimer’s disease.

Public health relevance
PROJECT NARRATIVE Understanding how specific neurons in a selectively vulnerable region such as the entorhinal cortex are affected is critical to unraveling the mechanisms underlying Alzheimer's disease onset. Using in-vivo single-unit electrophysiology recordings and optogenetics we will identify if excitatory neurons or inhibitory neurons or both are more vulnerable to Alzheimer’s disease pathologies. We will use chemogenetic approach to reduce pathology and restore neuronal function.